Proteomics Shared Resource

PROTEOMICS SHARED RESOURCE (PSR): PROJECT SUMMARY
The Siteman Cancer Center (SCC) Proteomics Share Resource (PSR) has been a major contributor to the
emerging field of proteogenomics with a track record of high impact publications and external funding. The PSR
is poised to continue as leaders in the field in the next five years, using reproducible and repeatable deep-scale
proteomics (≥ 10,000 genes) and phosphoproteomics (≥ 37,000 sites) and the harmonized protocol that was co-
developed with the National Cancer Institute Clinical Proteomics Tumor Analysis Consortium (CPTAC). Studies
are underway with comprehensively characterized Acute Myeloid Leukemia and pre/post treatment ovarian
cancer cohorts (Aim 1). In the current project period, PSR has developed high-precision assays for absolute
quantification (copies/cell) of 361 of the 526 protein kinases in the human kinome using CPTAC guidelines for
validation toward FDA approval and clinical utility. The PSR proposes to have complete coverage of the human
kinome by 2023 and to continue applying and developing cancer-type specific panels for PDX and human drug
trials (Aim 2). Proteomics is on the cusp of next generation instrumentation that will lead to quantification of all
expressed proteins and generate wider coverage of post-translational modifications. Using these new platforms,
and in collaboration with the recently-established Washington University School of Medicine (WUSM) Mass
Spectrometry Center, the PSR will develop new services for SCC members and increase the value and utility of
proteogenomic analysis in support of SCC research programs (Aim 3). Future directions for the next project
period include an emphasis on expanding services and enhancing cross-core interface to improve user
experience and interpretation of data. PSR will continue to develop software in collaboration with the
bioinformatic resources of the Genome Technology Access Center (GTAC) and The McDonnell Genome
Institute (MGI) with the overarching goal of providing tools for more efficient interpretation of high-density
proteogenomic data. WUSM recently recruited two faculty members who will contribute to PSR plans to expand
services in the next project period. Ben Major (MCBP), from the Lineberger Comprehensive Cancer Center at
the University of North Carolina, will serve as PSR Faculty Advisor and actualize expansion of PSR services in
the area of proximity-labeling mass spectrometry for high-specificity characterization of intracellular complexes
in cancer biology. With the successful recruitment of Dennis Goldfarb to WUSM and his agreement to collaborate
on development of new MS and bioinformatics tools for proteogenomics, PSR will offer members new capabilities
for facile discovery and hypothesis generation.